Metabolomic and genomic expansion of type 2 diabetes subtyping in multiethnic populations

Project Summary/Abstract
Type 2 diabetes (T2D) involves derangement in multiple tissues, yet the physiological drivers of disease will vary
and are difficult to discern for a given individual. This variability in T2D pathophysiology contributes to
heterogeneity in T2D complications and in which treatment strategy will offer optimum benefit. Together, these
pose challenges for clinical decisions on the optimal intervention. We and others have helped disentangle this
heterogeneity by advancing subclassification of T2D and identifying subtypes with different clinical risk, genetic
susceptibility, and response to interventions. However, multiple clinical gaps remain before T2D subtypes can
be used in routine clinical care, including a lack of racial/ethnic diversity in study populations, understanding of
T2D subtypes across the age spectrum, and integration of multiple different data types to provide comprehensive
understanding of the physiological drivers of heterogeneity in T2D. This application is in response to RFA-DK-
23-019, which seeks to establish a consortium to bring together investigative teams to improve classification of
T2D. We propose to contribute to this consortium and provide data from the Atherosclerosis Risk in Communities
Study, Coronary Artery Risk Development in Young Adults Study, Diabetes Heart Study (DHS), African American
DHS, Hispanic Community Health Study/Study of Latinos, Insulin Resistance Atherosclerosis Study (IRAS),
IRAS Family Study, Action for Health in Diabetes Trial, Multi-Ethnic Study of Atherosclerosis, and SEARCH for
Diabetes in Youth. These 10 populations total 55,766 individuals (25% prevalent T2D, 8% incident T2D) and
reflect the diversity of the US population at risk for and with T2D, spanning ages 10 to 86 years at enrollment,
and include large numbers of females (57%), Black (21%), and Hispanic (37%) individuals. We have a
multidisciplinary team with expertise in biostatistics, clinical diabetes care, data science, epidemiology, genetics,
metabolomics, and physiology. We have led developments in diabetes subgrouping and novel computational
methods to estimate missing data that will be used as a framework for broader application in this proposal. Aim
1 will assemble, harmonize, and integrate clinical, genetic, metabolomic, social determinants of health (SDoH),
and disease outcomes data across these cohorts. Aim 2 will build and cross-validate data-type distinct and
aggregate models for classification of T2D subtypes based on clinical, genetic, and metabolomics data. Aim 3
will assess T2D subtypes with risk for cardiovascular disease (and subtypes coronary heart disease,
cerebrovascular disease, and heart failure), chronic kidney disease, retinopathy, and mortality. We will also
assess the influence of SDoH on these relationships. Successful completion of this proposal will generate
evidence needed to establish physiological drivers of and precise definitions for T2D subtypes. This work furthers
our long-term goal of developing more efficient precision medicine-based prevention and treatment strategies
for T2D that maximize benefits and minimize risk for adverse outcomes.

Public health relevance
Project Narrative This proposal seeks to contribute to a consortium of studies that will generate new knowledge on the physiological drivers of type 2 diabetes subtypes by providing an expert team and an extensive array of data from existing studies. We will use hard-clustering and soft-clustering statistical methods coupled with phenotypic, genotypic, and metabolomic data to develop a framework for identifying reproducible and physiologically driven subtypes of type 2 diabetes. We believe that this information will be used by clinicians and patients to better guide type 2 diabetes prevention and treatment strategies.